IMMUNOREGULATION AND IMMUNE RECOGNITION IN FILARIASIS AND NON-FILARIAL DISEASES

The purpose of this project is to delineate the mechanisms involved in regulating immune response in filarial and nonfilarial disease states. Immunoregulatory studies have examined the phenomenon of antigen-specific anergy in microfilaremic patients by showing this anergy to be a result of a diminished frequency of proliferating cells to parasite antigen and of the production of the antiproliferative cytokines, IL-10 and TGF-beta. Filter immunoplaque assays for the major cytokines have been developed and used to demonstrate that in helminth infections of humans there is an expansion of Th2 CD4+ cells. The phenotypic characterization of these TH2 CD4+ cells has shown them to be CD45RO+ HLA-DR+ CD27-. The underlying genetic basis for the immune responses to certain parasite antigens is currently being studied.